Unfolding the role of misfolded proteins in smooth muscle cell phenotypic modulation and atherosclerosis

PROJECT SUMMARY
Coronary heart disease is the leading cause of death in the US. The atherosclerotic process underlying
coronary heart disease is exacerbated by stressors in the vascular environment, including hyperlipidemia,
tobacco smoke, and air pollution. These stressors have been known to cause increased inflammation and
oxidative stress in the vessel wall, but how these stressors affect the different cell types in the vascular wall
has not been well-described.
In our preliminary studies, we found that atherogenic stress can induce significant transcriptional and
epigenetic changes consistent with proteotoxicity in the atherosclerotic vascular wall. In particular, we found
that e-cigarettes activate the unfolded protein response (UPR) in smooth muscle cells (SMCs), and that this
response may be dependent on the environment sensing aryl-hydrocarbon receptor (AHR) pathway. The
overall objective of this proposal is to characterize the smooth muscle specific misfolded protein aggregates
and their functionality. The central hypothesis is that the atherogenic environment can induce tissue-specific
protein misfolding and proteotoxic stress in vascular SMCs and that AHR can protect against atherosclerosis
by limiting the proteotoxic stress. In Aim 1, we will isolate and identify the misfolded protein aggregates that are
associated with atherosclerosis and different disease-causing stimuli. In Aim 2, we will assess the role of AHR
in modulating the vascular proteostasis network utilizing primary human coronary artery SMCs in-vitro.
Extending the results obtained from PI Dr. Kim’s NHLBI K08 career development award, the proposed
work will address a critical knowledge gap in understanding the role of proteotoxic stress in SMCs during
atherosclerosis. Ultimately, this work will shed light on novel pathways associated with risk for coronary heart
disease. The successful completion of this project will provide the foundation to apply for a larger grant (R01)
to address the effect of specific components of the vascular proteostasis network in controlling atherosclerosis.

Public health relevance
PROJECT NARRATIVE Coronary heart disease remains the number one killer in the United States and other developed countries. There is a great need to understand the mechanisms leading to coronary heart disease, particularly in response to environmental risk factors. This study will exploit our recent findings from an NHLBI K08-funded study to understand the role of maladaptive protein aggregation in the vascular wall and coronary heart disease.